Penn State Clinical and Translational Science Institute

PROJECT SUMMARY ABSTRACT - OVERALL
The Penn State Clinical and Translational Science Institute (CTSI) was formed in 2007 to accelerate the impact
of biomedical research on health. Penn State has almost $1 billion in research expenditures, and its College of
Medicine (CoM) and Penn State Health system serve about 2.0 million people in largely rural regions of central
PA. Penn State is the state's land-grant university, a research institution with a strong culture of interdisciplinary
team science and a health system committed to the people and communities in our area. We have developed a
growing outreach network and partnerships to better understand the communities' needs, address barriers to
prevention and treatment, and test novel approaches to health concerns across the lifespan and translational
spectrum. As a learning organization, we practice continuous evaluation and data-driven decision-making to
achieve continuous quality improvement. Our vision is to be the cornerstone of CTS throughout Penn State and
a leader in advancing rural CTS. A key component of our vision is that interdisciplinary teamwork and broad
engagement of stakeholders is critical to success. Our specific aims are:
Aim 1. Catalyze CTS by engaging researchers, providers and community partners. We will engage
researchers and establish unique partnerships across and beyond Penn State. We will capitalize on vast sources
of health-relevant data to inform novel approaches to health concerns and social and environmental implications,
particularly as they relate to our rural population. We will integrate rural community engagement and
collaboration through community activities, consultation services, workforce training, and pilot projects.
Aim 2. Promote CTS through innovation and investigator-centered research infrastructure that
accelerates protocol development and study completion while ensuring scientific rigor and
reproducibility. CTSI provides expansive research support and services to conduct CTS research and clinical
trials that meet the needs of the communities we serve. We will pursue the establishment of an academic Clinical
Informatics Research Division at the CoM and promote integration with the sophisticated informatics capabilities
across Penn State. These efforts will empower scientists across the University.
Aim 3. Effectively share resources and expertise through collaboration with other CTSA Hubs and the
Consortium. We are active members of the CTSA (Clinical and Translational Science Award) Consortium. We
will increase our interactions, focusing on Hub collaborations germane to rural communities.
Aim 4. Educate a new generation of health professionals and CTS scholars, and empower them to
conduct funded, innovative and interdisciplinary research. The Institute will be the focal point for the training
of a diverse and expanding CTS workforce of scholars and professionals across Penn State, the CTSA
Consortium and our new partnerships.

Public health relevance
PROJECT NARRATIVE - OVERALL The Penn State Clinical and Translational Science Institute advances clinical and translational science to improve health and combat disease. It does this through collaboration and team science across scientific fields, an infrastructure of research excellence and data-driven decision-making, strong partnerships, and educational opportunities for a diverse and expanding clinical and translational science workforce. This project builds on the lnstitute's cross-university foundation and generates innovation, enables efficient research, educates the existing and next generation of scientists, and focuses on the health needs of rural communities.